Explore a key nucleotide synthesis enzyme to develop a broad-spectrum antiviral therapy.

Title: Explore a key nucleotide synthesis enzyme to develop a broad-spectrum
antiviral therapy
Co-PI: Pinghui Feng (contact) and Chao Zhang
With highly infectious viruses rapidly emerging and re-emerging (such as SARS-Coronavirus,
influenza virus and drug-resistant herpes simplex viruses), the human society is challenged with
limited options to treat diseases associated with these human viruses. In fact, antiviral therapies
that effectively thwart the infection of a broad spectrum of viral pathogens are long sought in the
antiviral community.
In studying viral immune evasion, we have discovered that diverse viruses, including SARS-
CoV-2, herpes simplex virus 1 (HSV-1) and influenza A virus (IAV), activate a key nucleotide
synthesis enzyme not only to fuel nucleotide supply, but also block antiviral inflammatory cytokine
production, thus efficiently promoting viral replication. We aim to target the key nucleotide
synthesis enzyme for inhibition, which will deplete nucleotide supply and restore antiviral immune
response to impede their replication. To achieve this goal, we have engineered conditional
knockout and knockin mouse strains that will enable the genetic interrogation of the enzyme-
mediated evasion of inflammatory response and metabolic reprogramming during the infection of
SARS-CoV-2, IAV and HSV-1. Teaming up with a chemical biologist (Dr. Chao Zhang, University
of Southern California), we have synthesized a library of small molecules and characterized
specific inhibitors of the nucleotide enzyme. Furthermore, we will collaborate with a structural
biologist (Dr. Santiago Ramon-Maiques, Instituto de Biomedicina de Valencia, Spain) to perform
structure-activity relationship (SAR) analysis to further improve the lead small-molecule inhibitors.
This study will provide a proof-of-concept to target a nucleotide synthesis enzyme in an effort to
combat the infection of key human viral pathogens.

Public health relevance
Project Narrative Modern human society is suffering more often with emerging and re-emerging infectious agents as evidenced by the ongoing COVID19 pandemic. Broad- spectrum antiviral therapy is an ultimate solution to the daunting challenge. This study will explore the possibility to target a cellular nucleotide synthesis enzyme to deplete nucleotide supply and restore inflammatory antiviral defense, thereby effectively impeding the infection of diverse RNA and DNA viruses.